A large-scale quasi-experimental evaluation of added sugar warning labels in restaurants

PROJECT SUMMARY
In November 2023, New York City (NYC), NY became the first jurisdiction in the US to adopt an added sugar
warning policy, which requires restaurants to display a warning label on menus next to items high in added
sugar. The adoption of this policy has the potential to reduce the burden of nutrition-related chronic diseases,
including obesity, type 2 diabetes, and heart disease. However, almost no real-world studies have examined
whether added sugar warning labels affect purchases of restaurant foods. Moreover, no real-world studies
have examined for whom these warning effects are largest. Also unknown are the psychological mechanisms
that could explain how added sugar warning labels change behavior. The Warning Impact Model has
established that cigarette and beverage warnings change behavior by changing thoughts, feelings, and beliefs,
but has never been applied to added sugar warnings. We will determine whether, for whom, and how added
sugar warnings affect restaurant purchases. All Aims will use a rigorous quasi-experimental design (difference-
in-differences) that assesses changes in purchases in NYC from before to after the warnings are implemented,
net of changes in comparison sites without warnings over the same period. We will combine two
complementary data sources. First, we will partner with MFour, an innovative mobile phone app with whom we
have completed a rigorous pilot test. Using MFour’s ability to send location-based surveys to a panel of
participants, we will prospectively collect receipts from customers exiting chain restaurants in NYC and
matched comparison sites. We will collect 4 repeated cross-sections of data (2 before and 2 after warnings are
implemented, total n=10,000 customers). We will also collect information on customers’ demographic
characteristics and their thoughts, feelings, and beliefs about added sugar. Second, we will obtain a dataset of
every purchase made at Taco Bell restaurants nationwide (including >3 million transactions per year in NYC
alone) from 2023-2028. We will use these data to examine whether added sugar warnings reduce total sugar
purchased from chain restaurants (Aims 1.1 and 1.2) and to determine whether this effect differs for customers
with lower education, lower income, or Black or Hispanic identities (Aim 2). We will also use these data to
determine whether added sugar warnings lead to more negative thoughts, feelings, and beliefs about added
sugar (Aim 3). Our central hypothesis is that added sugar warning labels will reduce total sugar purchased
from restaurants in NYC relative to comparison sites, with larger reductions among customers with lower
education, lower income, and Black or Hispanic identities. Completion of these Aims could lay the groundwork
for the adoption of added sugar warning labels across the US to reduce obesity, type 2 diabetes, and other
nutrition-related diseases.

Public health relevance
PROJECT NARRATIVE Sugar consumption is a major contributor to nutrition-related chronic diseases including obesity, type 2 diabetes, and heart disease. A policy that requires added sugar warning labels on restaurant menus has the potential to reduce population-level consumption of sugar and lessen the burden of nutrition-related chronic diseases, especially for population groups with higher sugar consumption. This project will evaluate whether, for whom, and how the nation’s first added sugar warning policy affects restaurant purchases.